Columbia Integrated Training Program in Infectious Diseases Research

Project Abstract
This is a renewal application from the Columbia University Medical Center (CUMC) for a post-doctoral training
grant in Infectious Diseases entitled “Columbia Integrated Training Program in Infectious Disease Research (TP-
IDR)”. Drs. Scott Hammer and Franklin Lowy will remain as principal investigators (PIs) under the multiple PI
NIH model. Both are established investigators with complementary research interests and longstanding
commitments to the training of new investigators. The goal of this proposal is to train post-doctoral fellows with
MD or MD-PhD degrees who are destined for academic infectious disease careers. The interdisciplinary program
is designed to provide the necessary skillset to successfully pursue translational research whether this research
be primarily basic or clinical/epidemiological. The dramatic advances in the fields of microbial genomics and
biomedical informatics and the potential application of these rapidly evolving tools to translational research has
necessitated a reappraisal of our approach to training new investigators. The ongoing recruitment to CUMC of
world class investigators (e.g., Dr. Megan Sykes, Center for Translational Immunology; Dr. David Goldstein,
Institute for Genomic Medicine) combined with pre-existent strengths in Infectious Diseases, pathogen discovery
(Dr. Ian Lipkin, Center for Infection and Immunity), Biomedical Informatics (Dr. George Hripcsak) and retroviral-
host protein interactions (Dr. Stephen Goff, Howard Hughes Medical Institute) has allowed us to construct a
Training Program that can recognize and nurture talented individuals. The TP-IDR, newly established in the
current funding cycle, is not only producing new investigators but is also stimulating new interest in Infectious
Disease research more broadly at CUMC. Resubmission is being sought to continue the success demonstrated
thus far and to secure its future. Drs. Hammer and Lowy will continue to co-chair the Executive Steering
Committee that serves as the governing body. A Recruitment and Candidacy Subcommittee will insure that our
applicant pool is strong and diverse. A dynamic mix of well-established and junior investigators has been
assembled to form a close-knit, dedicated faculty. Trainees selected to the TP-IDR have a choice of laboratory-
based or clinical/epidemiological-based research projects and have the option of obtaining a Master’s degree in
either Epidemiology or Biomedical Informatics. Didactic conferences and integrated TP-IDR seminars
complement the educational experience. Mentorship, training, career development and feedback are thorough.
An Advisory Committee, including members from within and outside the institution, will assist with oversight of
the program. Institutional support is strong and broad-based. The intersection of microbial genomics, biomedical
informatics and pathogenesis with clinical investigation, translational research, epidemiology and global health
form the conceptual vision of the TP-IDR. This program permits us to train the academic Infectious Disease
leaders of the future.

Public health relevance
Project Narrative This is an application for a renewal from the Columbia University Medical Center (CUMC) for a post-doctoral training grant entitled the “Columbia Integrated Training Program in Infectious Disease Research” (Drs. Scott Hammer and Franklin Lowy, principal investigators). The goal of this proposal is to train postdoctoral fellows with MD or MD-PhD degrees in state-of-the-art infectious disease research technologies and information handling. This interdisciplinary program will provide trainees with the necessary skillset to become leaders in the field of Infectious Diseases and thereby be in position to meet the infectious disease threats of the future and protect the public health.